Regulation of the Autophagy Pathway with Age and in Long-lived Animals

PROJECT SUMMARY
Macroautophagy (referred to as autophagy) is a major cellular recycling process by which cytosolic material is
sequestered into double-membrane vesicles or autophagosomes (i.e., early steps of autophagy), which
subsequently fuse with lysosomes to ensure cargo degradation (i.e., late steps of autophagy). This complex,
multi-step process plays key roles in organismal development and age-related diseases, and numerous direct
links exist between autophagy and aging, including that multiple conserved longevity paradigms require
autophagy genes for their lifespan extension; the current paradigm suggest that such long-lived animals induce
autophagic turnover in a beneficial manner, yet the underlying mechanisms remain elusive.
Our research in the previous funding cycle has provided a deeper understanding of the relationship
between autophagy and aging in the nematode C. elegans. First, our work using cytological markers has
indicated an age-related decline in late-steps of autophagy with variable trajectories in different tissues.
Moreover, we have observed a differential regulation of autophagy in long-lived mutants in a tissue-specific
fashion. Second, we have discovered unexpected longevity roles for specific autophagy genes in C. elegans
neurons, indicating possibly non-canonical functions different from lysosomal degradation, an emerging
concept in the autophagy research field which has yet to be investigated in the context of aging. Finally, we
have conducted unbiased genetic and biochemical screens to identify new candidate autophagy regulators and
receptors, and together with our collaborators identified a small compound that increase autophagy in both
mammalian cells and in C. elegans and extends lifespan.
Our prior studies provide us with new and specific hypotheses that we aim to test in depth in this renewal.
Specifically, we will use a powerful combination of genetic and biochemical approaches to ask if fusion- and/or
lysosomal degradation is a limiting step of the autophagy process in relation to organismal aging and longevity
(Aim 1); we will ask if neuronal autophagy genes affect aging by cell non-autonomous means (Aim 2); and,
finally, we will ask if new candidate autophagy receptors and autophagy-modulating molecules possess roles
in longevity and in disease models (Aim 3).
Autophagy plays critical roles in many disorders, including age-linked diseases such as neurodegeneration.
Understanding the regulation of autophagy and the conserved mechanisms by which autophagy affect aging in
multicellular organisms like C. elegans are likely to provide new important insights not only into aging and may
also help develop treatments for such age-related diseases, including neurodegenerative disorders.

Public health relevance
PROJECT NARRATIVE The US population of elderly people is rapidly growing and age-related diseases constitute a major health issue in our society; however, the cellular and molecular basis of aging and age-related disorders is poorly understood. This proposal aims to determine how autophagy – a cellular process of cytoplasmic degradation with major biological functions – modulates organismal aging. The proposed research has relevance to public health, because the mechanisms to be investigated are evolutionary conserved and the findings might ultimately provide therapies to treat aging-related diseases.